MULTICENTER TRIAL OF DICHLORPHENAMIDE IN PERIODIC PARALYSIS

The purpose of this study is to determine the efficacy of dichlorphenamid (DCP) in reducing the frequency and severity of attacks of periodic paralysis.